Environment, Epigenetics, Neurodevelopment & Health of Extremely Preterm Children

The goal of the second phase (2023-2030) of the Environmental influences on Child Health Outcomes (ECHO) Program is to extend and expand the ECHO Cohort to further investigate the impact of a broad range of early social and biological exposures during the preconception period and into young adulthood, on ECHO’s five key child health outcomes. Our pediatric ECHO cohort, ELGAN-ECHO, proposes to continue to 1) lead collaborative ECHO Cohort science, 2) follow up existing ECHO Cohort participants, and 3) implement the ECHO Cohort Data and Biospecimen Collection Protocol. The broad goals of this proposal are to: 1) evaluate predictors of exposure to environmental stressors (chemical and non-chemical) during preconception, pregnancy, and early childhood; 2) identify factors that have the potential to modify the relationships between environmental exposures, perinatal biomarkers of inflammation (e.g., epigenetic, genomic and proteomic) and neurodevelopmental outcomes (proposed specialty outcome areas); and 3) maximize retention of ELGAN participants. We will bring specialized expertise in environmental epidemiology related to metals, placental epigenetics, antecedents and correlates of preterm birth, and neurodevelopmental outcomes to the proposed project. In the first two years of the project (the UG3 phase) investigators from the ELGAN-ECHO team will collaborate with the ECHO Program to collaborate on the development of the ECHO Cohort Protocol for the preconception period and harmonization of data; lead and participate on ECHO committees, working groups, and task forces; plan participant follow-up, obtain approval for conducting the ECHO Cohort Protocol with oversight from the ECHO Cohort Consortium’s single IRB; reconsent existing ECHO Cohort participants; implement the ECHO Cohort Protocol for collection of data and biospecimens specified in that protocol; use the central data capture system to populate the ECHO Cohort Data Platform; retain study participants; and produce and disseminate ECHO Cohort science through publications and other public presentations. In the following five years (the UH3 phase) we will expand development, production, and dissemination of ECHO Cohort science, and continue to lend expertise on maintaining high retention rates and fidelity to the ECHO Cohort Protocol. Our over-arching perspective will be solution-oriented research questions that take advantage of the large sample size and longitudinal nature of the ECHO Cohort and have potential to influence practices, programs, and policies to improve children’s health.

Public health relevance
Exposure to chemical and non-chemical stressors increases the risk of neurodevelopmental impairments, including autism spectrum disorder. Still, the precise timing of exposure, key components of mixtures, and levels of stressors are understudied. The public health impact of the ECHO-ELGAN project lies in addressing key scientific gaps related to how chemical/non-chemical stressors interact and influence children’s neurodevelopment; the findings from the proposed research will inform prevention of neurodevelopmental impairments in U.S. children.